Vet-LIRN Portal

Project Summary/Abstract
The UMN Veterinary Diagnostics Laboratory and Food Protection and Defense Institute (FPDI)
propose the development and operations of a Vet-LIRN portal; a collaborative suite of online
tools that reside on the CoreSHIELD Information Technology platform. Capabilities include
customized working groups, web-based proficiency testing registration and management, and
tools that support secure information sharing among animal health and veterinary diagnostic
stakeholders. Collectively, the CoreSHIELD suite of tools is a sustainable model built and
operationalized for secure communication, coordination, collaboration, education, and training
among stakeholders charged with protecting the nation's critical infrastructures such as food
and agriculture. This proposal focuses on two main objectives:
1. Develop tools that advance Veterinary Laboratory Investigation and Response Network
(Vet-LIRN) laboratories’ capacity to respond to animal food/drug related contamination
through efficient online data capture and management of laboratory capabilities and
proficiency testing results.
2. Facilitate secure information sharing and communication for enhanced animal and public
health.
CoreSHIELD tools allow professionals working in different organizations (e.g. government,
academia) to work together on essential missions and responsibilities despite differences in
authorities, objectives, and roles. This robust platform connects the community stakeholders to
a centralized online environment and houses databases of current information related to the
mission of the Vet-LIRN to include but not limited to laboratory testing protocols, facilities,
equipment and professional expertise and contacts. Current CoreSHIELD Information Sharing
Environments (ISEs) include the Food Emergency Response Network (FERN-
https://www.fernlab.org) and the APHIS Laboratory Portal (https://www.nahln.org), formerly
called the National Animal Laboratory Network Portal.
The work is critical as FDA monitors the capability and performance of state, and university
animal diagnostic laboratories to respond to threats; from past intentional melamine
contamination in pet food to emerging antimicrobial resistance of bacterial pathogens.

Public health relevance
Project Narrative The University of Minnesota’s Food Protection and Defense Institute (FPDI) and UMN Veterinary Diagnostic Laboratory propose to deploy a customized Knowledge Management Portal utilizing the CoreSHIELD IT infrastructure to optimize and improve the sharing of animal health and veterinary diagnostics information, laboratory capabilities, and research projects within the Vet-LIRN network. The methods utilized by the CoreSHIELD tools will improve the capabilities and capacity of laboratories to investigate potential animal foodborne illness outbreaks or contamination events. This project will leverage the existing CoreSHIELD platform, in particular the laboratory directory (Lab-DIR) and Proficiency Testing Results Capture system (PT Module) utilized by the Food Emergency Response Network (FERN) and the APHIS Laboratory Network portal, formerly called the National Animal Laboratory Network (NAHLN) portal.